USE OF HUMAN TISSUE OPTICAL PROPERTIES TO ASSESS BLOOD GLUCOSE CONCENTRATIONS

New infrared technology may allow blood glucose levels to be measured in vivo without pricking the finger or breaking the skin. A specialized spectrophotometer can potentially detect the pattern associated with glucose in blood vessels near the surface of the skin in the extremities. The accuracy of this non-invasive technology to measure blood glucose levels and the changes in blood levels will be assessed. This is a pilot study to determine the performance of the device.